Molecular mechanisms underlying glial inflammatory responses to Neisseria meningitidis: A pilot study

Project Summary
Neisseria meningitidis is the causative agent of meningococcal meningitis, which can lead to epidemics with a
fatality rate of up to 50% in untreated patients. In addition, up to 20% of survivors of such infections show
permanent CNS deficits due to severe neuroinflammation, a hallmark of meningitis. It is now appreciated that
resident glial cells, including microglia and astrocytes, play a key role in initiating such damaging inflammation
and do so following the recognition of conserved N. meningitidis motifs using an assortment of cell surface and
membrane-associated pattern recognition receptors (PPRs). Furthermore, the production of inflammatory
mediators by glial cells following the recognition of pathogen associated molecular patterns (PAMPs) can serve
as host environmental cues that direct changes in the bacterial transcriptome to promote further colonization
and virulence. For example, Neisseria expression and/or release of the lipooligosaccharide (LOS) and
peptidoglycan (PGN) stimulates host cell production of inflammatory mediators, and these bacteria can modify
the lipid A component of LOS and release different amounts/profiles of PGN fragments that have been
demonstrated to influence host cell recognition and responses in non-CNS cell types. Intriguingly, N.
meningitidis has been reported to bind and import host cytokines that then drive changes in gene expression,
suggesting that cytokine responses serve as environmental cues to promote N. meningitidis virulence. To
date, the effect of specific LOS modifications and PGN fragment release on glial recognition and responses
has not been determined. Accordingly, this R03 pilot study will begin to address the hypothesis that N.
meningitidis PAMPs initiate glial immune responses that, in turn, feedback to regulate bacterial gene
expression to further exacerbate infection. These pilot studies are an essential first step in dissecting the
intimate relationship between N. meningitidis and glial cells that underlies the development of detrimental
neuroinflammation and will provide a solid rationale for future comprehensive investigations.

Public health relevance
Project Narrative Infection with Neisseria meningitidis triggers detrimental glial cell inflammatory responses that result in long term morbidity or mortality, but the host-pathogen interactions required for such responses are not understood. This pilot study will define the relative glial immunogenicity of N. meningitidis component variants, and the ability of these host responses to, in turn, direct Neisseria gene expression in such a way as to exacerbate CNS inflammation.